Quantitative and computational characterization of oxytocin receptor function

PROJECT SUMMARY
Approximately half of the four million women who give birth in the United States each year receive oxytocin to
induce or augment labor. However, the effective oxytocin dose varies by up to 20-fold, and there is no way to
predict individual response. This unpredictability raises safety concerns since oxytocin use is associated with
adverse maternal and neonatal outcomes. One way to decrease morbidity associated with oxytocin is to be able
to predict individual response and personalize dosing regimens. In order to do this, we need a better
understanding of oxytocin receptor (OXTR) function and dynamics. In the previous funding period, we addressed
this issue by constructing an initial computational model of oxytocin-OXTR binding using available binding affinity
data for the OXTR. We validated this model by showing that it recapitulates the experimentally established
oxytocin dose response for oxytocin-OXTR binding in both a heterologous cell line and in a myometrial cell line.
However, we were unable to accurately expand our model beyond the initial oxytocin-OXTR complex formation
due to a lack of OXTR- and cell-specific kinetic data. In this next phase, our objective is to fill this gap by
conducting experimental studies on OXTR to quantitatively define key steps in trafficking of the OXTR in uterine
smooth muscle (myometrial) cells, including membrane insertion, internalization, and recycling dynamics. We
have substantial published and preliminary data giving us confidence in our ability to achieve our objective. First,
we identified OXTR genetic variants that exhibit reduced trafficking and localization to the cell surface and an
attenuated response to oxytocin. Second, our rigorous quantitative analyses revealed that only 10% of
endogenous OXTR is localized on the cell surface in myometrial cells. Third, we found that, after four hours of
oxytocin exposure in vitro, OXTR is degraded rather than recycled to the cell surface, thereby depleting the pool
of OXTR available for activation. Finally, we identified several small molecules that act as pharmacologic
chaperones to enhance OXTR cell surface localization. Given these data, our central hypothesis is that
enhancing OXTR cell-surface localization can improve the efficacy of oxytocin. We propose to test our central
hypothesis while conducting rigorous kinetic experiments to discern fundamental principles of OXTR action and
develop data-driven, computational models to predict oxytocin responsiveness. We will pursue the following
three specific aims: Aim 1: Determine the kinetics of OXTR surface localization and activation in cells, 2)
determine the dynamics of OXTR desensitization and recycling in cells, and 3) determine OXTR responsiveness
in vivo in mice and ex vivo in human tissues. The research proposal here will obtain experimentally obtained
quantitative kinetic data on the OXTR. We will use this to build a computational model to predict OXTR response,
which will allow us to better understand the effects of oxytocin signaling on myometrial contractility. Ultimately,
this will move us to our ultimate goal of creating a computational model that can be used to improve clinical
oxytocin use and obstetric outcomes.

Public health relevance
PROJECT NARRATIVE Oxytocin, the most commonly used drug in obstetrics, is administered to an estimated two million women in the U.S each year for labor induction and augmentation. A significant challenge for providers is they cannot predict how, or even whether, an individual will respond to a given oxytocin dose. The purpose of these experiments is to define steps that move the oxytocin receptor to the cell surface and use this data to develop a model that can be used to test factors that influence how the oxytocin receptor functions in the uterus.